Reducing Particulate Matter-Associated Cardiovascular Health Effects for Seniors

Project Summary/Abstract
Fine particulate matter <2.5 µm (PM2.5) air pollution is the fifth leading risk factor for mortality worldwide.
Over 88 thousand deaths per year are attributable to PM2.5 in the US alone, with the largest portion from
cardiovascular (CV) causes (myocardial infarctions, strokes, heart failure). Despite improvements across the
US, PM2.5 remains above World Health Organization Air Quality Guidelines (<10 µg/m3) in numerous hot-spots
(e.g., near roadways). Therefore, it is critical to develop feasible and effective personal strategies to protect
“vulnerable” (urban/near-roadway) and “susceptible” (elderly) populations at risk from the harmful effects of
PM2.5.
Emerging trials have shown that portable indoor air filtration units (AFUs) with high-efficiency particulate
arrestance filters can reduce PM2.5 exposures by 30-50% and improve CV health endpoints (e.g., BP, vascular
function). Our recent clinical trial results confirm that even low PM2.5 levels pose significant risks to CV health
and that portable indoor air filtration units (AFUs) represent a promising preventative strategy. However, no
study has addressed whether exposure reductions and health improvements can be sustained over more
clinically relevant periods of intervention (i.e., several weeks) which are required to plausibly yield decreases in
actual CV events. In addition, the efficacy of the novel practical (i.e., less expensive and more feasible in real-
world settings) approach of using a single AFU only in the bedroom to focus on reducing nocturnal PM2.5
exposure is currently unknown.
This proposal seeks to conduct a randomized double-blind 3-way crossover intervention study (AFUs in 2
rooms vs. bedroom AFU use alone vs. sham filtration) in 50 adults living in a low-income senior residence
impacted by roadway pollutants. Specific Aims are: (1) determine if long-term, 2-room AFU usage provides
sustained reductions in PM2.5 exposure and persistent improvements in cardiometabolic outcomes; (2)
determine if nocturnal PM2.5 exposure reduction alone improves cardiometabolic outcomes; and (3)
demonstrate the key role of adrenal activation as a novel mechanism explaining PM2.5-induced cardiometabolic
changes. Our proposal will help validate the benefits of novel strategies to employ AFUs in an elderly
vulnerable population. Positive results would represent a key step in forming the evidence base required to
promote more wide-scale AFU use; in the long term, given their low cost and burden, AFU use could be up-
scaled to help protect diverse populations.

Public health relevance
Project Narrative Exposure to fine particulate matter (PM2.5) air pollution is an established risk factor for cardiovascular (CV) morbidity. This proposed study seeks to investigate the effectiveness of portable indoor air filtration units (AFUs) at mitigating personal exposures to airborne PM2.5 and reducing air pollution-related cardiometabolic health effects on elderly residents in a residential facility. New insights are anticipated regarding (1) the cardiometabolic effects of long-term AFU usage, (2) cardiometabolic effects of nocturnal-only PM2.5 exposure reduction, and (3) the key role of adrenal activation as a novel mechanism explaining PM2.5-induced cardiometabolic changes. This intervention study has the potential to reduce the incidence of CV events in this and other highly susceptible populations.